PROTEOMIC ANALYSIS OF MICRODISSECTED BENIGN AND MALIGNAN

We will study the differences in cellular protein expression between normal and pathological thyroid tissues using proteomics technology, and identified several proteins that are differentially expressed in thyroid lesions with both benign and malignant proliferative potential. The continuation of this line of work will hopefully lead to the discovery of new molecular markers important in the diagnosis and treatment of Thyroid Ca.